INVESTIGATION OF AUDITORY/VESTIBULAR DYSFUNCTION OF UNDETERMINED CAUSE

Develop procedures for diagnosis of perilymphatic fistula--a surgically correctable cause of unexplained sensorineural hearing loss and/or vertigo in children).